Automated Health Assessment through Mobile Sensing and Machine Learning of Daily Activities

PROJECT SUMMARY / ABSTRACT
The world's population is aging and the increasing number of older adults with Alzheimer's disease and
related dementias (ADRDs) is a challenge our society must address. While the future of healthcare availability
and quality of services seems uncertain, at the same time advances in pervasive computing and intelligent
embedded systems provide innovative strategies to meet these needs. Two particular needs which technology
can help address is early detection of cognitive and physical decline, and tracking integration of new, healthy
brain behaviors into everyday life. The long-term goal for Adaptelligence LLC is to commercialize a smartwatch
app, called AcTelligence, to assess a person's cognitive and physical health and to promote healthy brain
behavior. The objective of this application is to perform research a development to refine and commercialize a
smartwatch app that offers capabilities to detect activities of daily living from smartwatch sensors, extract
digital behavior markers from activity-labeled sensor data, predict clinical health measures from behavior
markers, and provide user feedback in the form of health status and healthy-behavior prompts. This technology
is unique because we consider a person's entire behavior profile and introduce machine learning methods to
robustly predict clinical measures from this information. We utilize a popular smartwatch platform to increase
accessibility and balance continuous assessment with opportunities to extend and improve health. Building on
our successful Phase I effort, our approach is to extract activity-aware digital behavior markers from
smartwatch sensor data (Aim 1), automate health assessment based on these markers (Aim 2), and perform
participatory design of a web dashboard that provides visual analytics and alerts for brain health (Aim 3). We
will validate the sensing and machine learning technologies for a sample of 100 older adults and will refine the
interactive analytics through multiple rounds of participatory design with 18 participants. The app will be
brought to market through a thorough market analysis and a strategically-designed commercialization plan.
The proposed contributions are significant because they will provide insights on cognitive and physical health
revealed within a person's everyday environment that promote early detection of cognitive and physical decline
that can lead to more effective treatment. This work is important because of the increasing number of older
individuals experiencing cognitive and functional limitations due to chronic health conditions. Furthermore,
the work addresses the need for individuals to remain functionally independent as long as possible in their own
homes, thereby improving quality of life and reducing health care costs.

Public health relevance
PROJECT NARRATIVE We propose to perform research and development to refine and extend a commercial application that can predict an individual's cognitive and mobility-based health using patterns learned from sensor data collected from a smart watch, and effectively and efficiently present this information to the caregiver. The application also provides opportunities to learn about healthy brain behavior and to track the integration of these behaviors into a person's routine. This research is relevant to public health because these technologies can extend the functional independence of our aging society through technology-assisted health self-management, reduce caregiver burden, and improve quality of life.